Career Enhancement Program

PROJECT SUMMARY
The goal of the Leukemia SPORE Career Enhancement Program (CEP) is to recruit and support new investigators in the field of translational leukemia research. To accomplish this objective, the CEP program will provide financial support and mentored research training. The CEP will leverage Institutional strengths to recruit basic scientists and clinical investigators from varied disciplines to promote multidisciplinary translational research. The following specific aims are proposed: Aim 1: We will recruit and support new investigators in the field of translational leukemia research. A total of $185,000 has been committed annually to support CEP researchers. We will fund CEP awardees annually at $75,000 per year for up to two years. Aim 2: We will provide training and mentoring to junior faculty in translational leukemia research. CEP awardees will be co-mentored by a senior basic science and clinical mentor. In addition to mentored research training, CEP will work with new investigators to craft an individualized career development plan that may combine didactic coursework, patient care, and career skills tailored to their individual goals. Aim 3: We will foster inter-SPORE collaborations. We have established educational exchanges to provide CEP awardees the opportunity to present their research and meet with the leadership at a peer Leukemia SPORE Institution.